Summer Research in Environmental Health Sciences

PROJECT SUMMARY
The Summer Undergraduate Research in Environmental Health Sciences (SURES) program at the University of
Kentucky is designed to introduce students to the highly interdisciplinary and collaborative nature of
environmental health science (EHS) research that is focused on solving key global health problems. An
additional focus is to prepare underprivileged and under-represented students for successful careers in relevant
fields. This is a competitive renewal application seeks support to continue our 10-week summer program and
support fellowships for 10 students. The SURES program leverages the substantial and ongoing efforts at the
University of Kentucky driven to enhance the undergraduate research experience with the robust environmental
health science research programs of involved faculty mentors. The specific aims are to 1) enhance student
understanding and interest in EHS and 2) improve student scientific and career skills. Towards this end, students
will be recruited from the Commonwealth of Kentucky with an emphasis on those from the Appalachian region
as well as from a variety of undergraduate institutions in order to create a cohort of participants representing
diverse populations. The SURES program will commence with a week-long session that introduces students to
research, laboratory safety and scientific ethics. The students will then experience hands-on research by
performing experiments in the laboratories of their chosen mentors. Professional development and a sense of
belonging to the EHS community will be built via student participation in weekly lunches with EHS researchers
and professionals, net-working opportunities and tours of research facilities. In addition, students will be paired
with a near-peer mentor and engage in weekly activities that include a “citizen science” lead collection group
exercise, a theatre improvisation workshop, community-building circle on mentoring, “painting their projects” and
viewing a discussing a film on climate change. Each participant will create an EHS-relevant podcast. The
SURES program will culminate in a campus-wide poster session attended by the faculty, staff, students and
student family members. Success of the program is indicated by the engagement of prior participants in careers
in university research (13%), industry (16%), government/nonprofits (11%) and pursuing graduate (16%)
/professional (37%) education. Dissemination of the approaches used in this program and their outcomes will
build upon the expansion of the traditional environmental health sciences research training from the graduate
and post-doctoral level to the undergraduates at a national level.

Public health relevance
NARRATIVE The overall objective of the Summer Undergraduate Research Experience in Environmental Health Sciences (SURES) program is to use a research-intensive approach for introducing students from the impoverished region of Appalachia to the multidisciplinary nature of environmental sciences and opportunities for pursuing relevant careers. Exceptional training in a wide variety of research areas working with interdisciplinary collaborative research groups who are housed in multiple departments and colleges is provided. In addition, seminars, outreach opportunities and interactive workshops are designed to prepare students for successful, environmental health related careers.